Community Engagement and Outreach Core

During the last four years, the Community Engagement and Outreach (CEO) Core has conducted, promoted,
and advanced community-engaged and practice-based research in northern New England. We established
community engagement councils, built enduring community partnerships, strengthened our practice based
research network, and built a unique research navigator program to listen and learn from the communities we
served. Building on those successes, we seek to further enhance our efforts through innovative approaches to
community engagement and outreach. Improving public health depends on successful translation of findings
from basic science to clinical research and subsequently to clinical practice. This translational spectrum
requires strong connections to engaged communities. As we have seen over the last year, there have been
tremendous scientific successes in the fight against Covid-19, but not all communities have embraced them or
understood or trusted the science behind them. Engaging communities from the start, and conducting research
that is meaningful to them, is critical to the success of translational research and to building trust in and
understanding of science. Thus the long term goals of the CEO Core are to provide opportunities for
communities to identify their priorities for research; to build a robust structure and process for engagement
between communities and investigators; to engage investigators in research targeted at reducing health
disparities in our communities; and, to promote research across northern New England by expanding our
partnership with clinical and community-based organizations, State Departments of Health, and our partner,
the Northern New England Practice Based Research Network, formerly the Dartmouth/Northern New England
CO-OP. Our specific aims for this Core will focus on strategies to address the health needs of the communities
in Maine, New Hampshire, and Vermont. As such, we will engage investigators in research to address health
disparities and inequities in northern New England, consistent with national Healthy People 2030 goals and
community priorities. We will also increase northern New England community engagement capacity to identify
and prioritize community health challenges and participation in research. Finally, we will expand current
partnerships among academic centers, rural health care practices, Federally Qualified Health Centers,
community organizations and the Northern New England Practice Based Research Network to increase
community-based research projects. By accomplishing these aims, with a commitment to diversity and
inclusion and leveraging the expertise of the NNE-CTR Cores, we will implement a system of community
engagement, prioritize community health needs, and integrate social determinants and health equity into our
research priorities. In sum, we will create an environment in which academic centers, healthcare organizations,
community-based organizations, and community members can collaboratively pursue research that is essential
to improving health outcomes across northern New England.